Cell type-specific roles of integrin CD11b in atherosclerosis regression

Atherosclerosis is a disease of the arteries, with estimated health care costs around $400 billion in the US
alone in 2020, which are expected to triple to $1344 billion in 2050. Current lipid-lowering therapies are
effective at preventing the progression of atherosclerosis but are ineffective (~1%) at inducing plaque
regression. Given that a 1% reduction in plaque burden leads to a 20% reduction in the odds of cardiovascular
diseases, the development of new therapies that facilitate more efficient plaque regression is urgently needed.
The regression of atherosclerosis is a complex process that involves the clearance of cellular debris and
cholesterol/lipid deposits, as well as the removal of foam cells and proinflammatory macrophages, which is
largely mediated by non-foam cell macrophages. CD11b/CD18 (Mac-1 or αMβ2) is an integrin receptor highly
expressed on macrophages, yet its function in atherosclerosis regression remains poorly understood. Our
preliminary results revealed that the deletion of CD11b in LDLR−/− mice promotes the development of
atherosclerosis under hyperlipidemia, indicating that CD11b possesses novel atheroprotective functions. Using
CD11b-floxed mice, we discovered that this beneficial function of CD11b/CD18 is associated with resident
macrophages. Crucially, our preliminary data further revealed that CD11b/CD18 is essential for atherosclerosis
regression in LDLR−/− mice following the re-expression of LDLR. Mechanistically, we discovered that CD11b
possesses novel anti-inflammatory properties. Our recent preliminary data unveiled novel interactions between
CD11b/CD18, ATP-binding cassette transporter A1 (ABCA1), and Apolipoprotein A-1 (ApoA1), and they also
identified a key role of CD11b/CD18 in ABCA1-mediated cholesterol efflux from macrophages to HDL particles.
Based on these exciting preliminary results, we hypothesize that macrophage-specific CD11b, in
conjunction with ABCA1, promotes atherosclerosis regression by suppressing vascular inflammation
and enhancing cholesterol and lipid removal from the atherosclerotic plaques. To test this hypothesis,
we generated a reverse floxed ApoE−/− (revApoEKO) mouse model, where tamoxifen-induced re-expression of
ApoE results in significant plaque regression. We propose three Specific Aims in this application. In Specific
Aim 1, we will examine the role of cell type-specific CD11b/CD18 in atherosclerosis regression and investigate
the reversibility of atherosclerosis at various stages of disease development. In Specific Aim 2, we will
elucidate the molecular mechanisms by which a ternary complex of CD11b/CD18, ABCA1, and ApoA1
enhances cholesterol efflux efficiency. In Specific Aim 3, we will explore novel CD11b-targeting strategies to
promote atherosclerosis regression using two independent mouse models: LDLR−/− mice and revApoEKO mice.
Completion of this project will provide valuable insights into how CD11b/CD18, together with ABCA1 and
ApoA1, enhances the effectiveness of atherosclerosis regression following lipid-lowering therapy, ultimately
reducing the risk of cardiovascular diseases.

Public health relevance
Atherosclerosis (the hardening and narrowing of artery) is the underlying cause of cardiovascular diseases, with inflation-adjusted health care costs predicted to triple from $400 billion in 2020 to $1344 billion in 2050 in the US alone. Although lipid-lowing drugs have significantly reduced the risk of developing atherosclerosis; however, the goal to regress the existing atherosclerotic plaques in patients remains elusive. Completion of this project will help the design of more effective therapies to accelerate the regression of atherosclerosis.